Administrative Core

This Administration Core will provide the AADCRC Program with the management, coordination and supervision required for successful completion of the Program at the highest level. Our AADCRC proposal brings together several leading asthma investigators in a multi-project, multi-core application to focus on important questions in asthma pathophysiology. To meet this challenge, we have three co-principal investigators (co-PIs), Dr. Steve White, Dr. Carole Ober, and Dr. Jerry Krishnan. There are also six Co-Investigators (Co-Is) who provide additional depth and breadth of asthma expertise, as well as access to large numbers of patients with asthma. The grouping of three separate projects and four core services requires a strong administrative core to ensure the goals of the Program are realized. The Administration Core will provide administrative services for all projects and cores, including financial management and fiscal oversight, communications management including educational opportunities, and services for the Program Steering Committee. The chief administrator will assist the core director in providing these services.

Public health relevance
The Administration Core will provide administrative services for all projects and cores in this program.